Generation of intersectional genetic tools for advancing tendon and musculoskeletal research

Project Summary
Tendon and ligament injuries are widespread and affect young active to aging individuals. Once
injured, tendons undergo slow and limited healing and never regain their original properties. This
can result in limited mobility, pain associated with movements, and a high propensity for reinjury.
By gaining a mechanistic understanding of the cell types and pathways regulating tendon cells
during their formation, homeostasis, and repair, we hope to identify new potential ways to treat
tendon injuries and improve tendon healing in patients. Studies using mouse genetic approaches
have accelerated tendon research, identifying new tendon cell types and pathways that regulate
formation and healing. Constitutive and inducible tendon recombinase lines, such as Scx-Cre and
Scx-CreERt2, have been instrumental in allowing more tissue-specific gene loss of function
analysis. However, there remain limitations in our ability to target specific subsets of tendon cells
or to target tendons in distinct anatomical regions. Scx-Cre/Scx-CreERt2 as well as other
Cre/CreERt2 lines used to label tendons and ligaments are not specific to these tissues, which
can confound interpretation of cell lineage and functional studies. More specific tools are needed
in order to advance future research and enable studies dissecting specific tendon cell subsets or
anatomical regions. In the neuroscience field, intersectional genetic tools have been used for
more than a decade to target developmentally and molecularly distinct cell networks and dissect
their function. Therefore, we propose to generate new alleles that would enable intersectional
genetic approaches in the tendon and could be applicable to other musculoskeletal tissues. First,
we will generate constitutive and inducible Flp alleles that can be used with a large number of
existing Cre/CreERt2 lines and Flp/Cre indicator alleles for intersectional cell labeling. This would
allow specific targeting of subsets of tendon cells as well as targeting tendons in distinct anatomic
locations. In addition, we propose the generation of two Flp/Cre dual recombinase responsive
alleles for performing functional analysis of the intersecting cell populations via cell ablation or
expression of rtTA, which can be used for functional perturbations when combined with already
available TetO lines. Proper efficiency and specificity of all alleles will be validated using existing
indicator or Cre/Flp lines. Together, the generation of these alleles will permit unprecedented
targeting of specific tendon cell populations for lineage tracing and functional analysis. Their use
by the musculoskeletal community would enable mechanistic studies and advance research with
the goal of impacting the development of future tendon therapies.

Public health relevance
Project Narrative Our understanding of tendon cell function is limited by the ability to specifically target subsets of tendon cells during development, homeostasis, and healing. We propose to generate new mouse alleles that would enable an intersectional genetic approach and more specific targeting of tendon cells. Widespread use of these lines would advance our mechanistic understanding of tendon biology and would impact the development of therapies for human tendon injuries.